Investigation of the roles for CaV1.2 in non-excitable tissue during development

Although voltage-gated Ca2+ channels (VGCCs) have been studied extensively for their roles in neurons, heart, and hormone-secreting cells, the especially broad array of abnormalities in Timothy syndrome (TS) implies unexpected roles for VGCCs during development. TS is due to a gain-of-function mutation in CACNA1C, the gene encoding the pore-forming α1C subunit of the L-type Ca2+ channel CaV1.2. Intense focus on TS has centered on how the mutant channels lead to cardiac arrhythmias or autism, but almost no studies have examined CaV1.2 contributions to accompanying phenotypes such as syndactyly. Unraveling these CaV1.2 contributions will be fruitful, since these TS phenotypes include multiple common birth defects, implying that dysfunctional CaV1.2 signaling generally is a frequent cause of developmental abnormalities. Moreover, the consequences of dysfunctional CaV1.2 in birth defects demonstrates that CaV1.2 has important, but understudied roles in normal development. Here we propose three Aims: 1: Test the hypothesis that Ca2+ influx through TS mutant CaV1.2 affects interdigital apoptosis; 2: Test the hypothesis that Ca2+ influx through CaV1.2 controls bone development; and 3: Test the hypothesis that the developing mouse limb displays electrical signaling properties that regulate CaV1.2. To complete these aims, we have generated various knockin, knockout, and tissue-specific gain-of-function and loss-of-function mouse models, with which we obtained preliminary data demonstrating roles for CaV1.2 within the developing limb and within developing bone. Further, we have developed methods that build upon multiple technologies to permit live Ca2+ imaging in ex vivo limb cultures isolated from mouse embryos. These methods will provide an unprecedented characterization of parameters such as properties of spontaneous and evoked Ca2+ transients, resting membrane potential, dynamic changes in membrane potential, action potentials, and VGCC currents in developing limbs. Successful completion of these Aims will define novel roles for CaV1.2 in the development of tissues other than brain, heart, and endocrine tissue, thereby revealing mechanisms for many of the unexplained TS phenotypes. Because CaV1.2 anchors a large molecular complex, these studies will serve as a platform for future investigation of the roles of CaV1.2-associated proteins and their downstream signaling partners in development and whether their dysfunction also contributes to birth defects. The availability of clinically used agents that target CaV1.2 offers the opportunity to exploit the knowledge gained from the proposed experiments for new treatment paradigms.

Public health relevance
Public Health Relevance Statement This grant explores the role of CaV1.2 Ca2+ channels in development. Mutations in CaV1.2 Ca2+ channels lead to a variety of birth defects and knowledge derived from this grant will be helpful in understanding them and developing new treatment and prevention strategies.